PROTEIN TURNOVER AND ANABOLIC INTERVENTION IN AIDS

Cachexia, muscle wasting and weakness are common in individuals infected with HIV, and are associated with increased mortality. Our primary purpose is to describe the perturbations in protein metabolism that explain the muscle wasting associated with HIV infection by determining the rates of whole body and skelet-al muscle protein turnover, using stable isotope tracer methodology. Our second purpose is to determine whether two potential anabolic interventions (weight lifting and growth hormone treatment) can alter the rates of protein synthesis